Behavioral, molecular and sex-specific mechanisms of indirectly learned fear memory

Project Summary/Abstract
The broad goal of this proposal is to understand how fear memories are formed and stored in the brain. Post-
traumatic stress disorder (PTSD) affects nearly 5% of the world population, however, current treatments have
limited efficacy in reversing the symptoms of this disorder. Furthermore, females are more likely than males to
develop PTSD, though the mechanisms controlling this sex-dependent predisposition remain equivocal. While
established rodent fear conditioning models have aided in the elucidating the neurobiological mechanisms
supporting the formation of fear memories that underlie PTSD, these focus almost exclusively on the individual
experiencing the traumatic event. However, some cases of PTSD and associated anxiety disorders can be
acquired by witnessing a traumatic event happen to someone else in close proximity. Despite this, few studies
have examined the neurobiology of indirectly acquired fear memories and whether they differ from those of
memories for directly experienced traumatic events. Furthermore, whether there are sex differences in the
behavioral and molecular mechanisms of indirectly fear memories has yet to be explored. In our preliminary
studies using an indirect fear conditioning procedure in which an observer rat watches a demonstrator rat
associate an auditory cue with a mild footshock, we found that both male and female rats could indirectly
acquire fear memories. Genetic loss of Fmr1, which produces deficits in social behavior, resulted in an
enhancement of indirect fear memories, suggesting that social cues may not be the primary factor driving
empathetically acquired fear. Importantly, we found unique changes in protein degradation targets in the
amygdala of demonstrator and observer rats, suggesting unique molecular signatures for directly vs indirectly
acquired fear memories. The work in this proposal is designed to build off of these preliminary data and answer
important questions about the behavioral, molecular and sex-specific mechanisms controlling the formation of
indirectly acquired fear memories. Using genetic rat lines and specific manipulations to the training (learning)
experience, Aim 1 will systematically test the behavioral mechanisms (social, visual, olfactory, auditory) by
which indirect fear memories are acquired and how this varies by sex. Aim 2 will use whole genome
transcriptomic and proteomic approaches and well-established pharmacological manipulations to determine if
the formation of directly and indirectly acquired fear memories requires similar transcriptional, translational and
protein degradation mechanisms and whether this varies by sex. Collectively, this study will answer important
questions about the sex-specific mechanisms controlling the formation of memories for indirectly acquired fear
associations, which will be critical for the development of proper therapeutic interventions for the treatment of
PTSD that is acquired empathetically.

Public health relevance
Project Narrative - Relevance Using the Pavlovian fear conditioning paradigm, the proposed experiments outlined in this document will expand the current literature on the physiological underpinnings of fear memory storage. Enhanced understanding of the biological mechanisms underlying fear memory storage are important not only for increasing our basic knowledge of this process but also for the potential translation of research findings to both normal and disordered memory in humans.